EFFECTS OF CATIONS, ANIONS, AND WATER UPON BLOOD VESSELS

In this proposal emphasis is given the possible role of the electrogenic sodium-potassium pump in the genesis of experimental hypertension. It is now well established that the Na-K pump in blood vessels is in fact electrogenic. Studies in our laboratory indicate that the potassium ion is vasoactive by virtue of its effect on this pump, hyperkalemia dilating by stimulating the pump and hyperpolarizing the the membrane and hypokalemia constricting by suppressing the pump and depolarizing the membrane. Other studies in our laboratory suggest that the electrogenic pump is suppressed in experimental renal hypertension in dogs and rats and in essential hypertension in man. If so, this could in part explain the increase in total peripheral resistance. We propose to examine this hypothesis further by 1) examining the resistance response to hypokalemia and ouabain, 2) measuring tension responses of isolated arteries and veins to potassium and ouabain, 3) calculating active sodium pumping rate and membrane permeability in isolated arteries and veins from sodium 22 washout, membrane potential, and cell volume measurement, 4) measuring the membrane potential of the vascular smooth muscle cell in situ, and 5) measuring Na ion, K ion-ATPase and Ca ions-ATPase activity in red cell membranes and Na ion, K ion-ATPase activity of membranes from the vascular smooth muscle cell. All studies will be conducted in animals with spontaneous or experimental renal hypertension and in decreased active pumping, membrane potential and Na ion, K-ATPase activity would be compatible with the hypothesis. Another way a suppressed Na ion-K pump could contribute to the increased peipheral resistance is by "waterlogging" the vessel. We therefore propose to measure vascular smooth muscle cell volume during prolonged suppression of the ouabain sensitive Na ion-K ion pump to see if in fact such suppression increases cell volume.